Genomics Bioinformatics

PROJECT SUMMARY
Core B. Genomics Bioinformatics
A Genomics and Bioinformatics Core is proposed to enable the application of massively parallel sequencing-
based approaches to advance the understanding of pathological programs of gene expression that contribute to
the development of atherosclerosis and NASH. An essential aspect of all four Projects of this PPG will be to
define the consequences of genetic, dietary and pharmacologic perturbations on global programs of gene
expression in relevant tissues and cell types. The PPG Genomics and Bioinformatics Core will provide two
complementary services to advance these efforts; 1) technical support and resources for preparation and
sequencing of libraries enabling bulk RNA-Seq, single cell RNA-Seq, ATAC-Seq and ChIP-Seq assays and 2)
corresponding bioinformatics and computational support to allow effective analysis of the resulting data.